Administrative Core

Project Summary – Administrative Core
The Administrative Core of the Virginia Commonwealth University Alcohol Research Center (VCU-ARC) will
provide the centralized administrative functions of the VCU-ARC. This entails supervision and coordination of
five research projects (Projects 1-5), and two additional cores focusing on the Pilot Project program and a
Behavioral Core. Additional responsibilities will include outreach and teaching within VCU and dissemination
outside the University of accomplishments of the alcohol research program of the VCU-ARC. Overall scientific
and administrative oversight will be conducted by the Center and Scientific Directors (Drs. Miles and Bettinger),
with assistance from an Internal Advisory Committee and the Steering Committee, who will be responsible for
monitoring scientific productivity and integrity of the Center as well as the general scientific research direction
of the Center. An External Advisory Committee will assist the Directors and Steering Committee in scientific
and administrative oversight of the Center and selection of pilot projects for years 3 through 5. The
Administrative Core will assist active collaboration and communication between all Center components through
a series of biweekly meetings consisting of research presentations, literature reviews or seminars by invited
distinguished scientists in the alcohol research field. These will rotate with a Foundation of Alcohol Research
(FAR) lecture series on fundamental aspects of alcohol research. These meetings and invited seminars will be
open to the VCU research community to encourage expansion of alcohol research at VCU. The Administrative
Core will also contain a Data Analysis, Integration and Resource Sharing (DAIRS) component to directly assist
Center investigators in advanced analytical approaches, provide expertise and resources for data integration,
and provide portals (Google Drive, GitHub, VCU-ARC web site) for general information, data, protocols and
analysis code sharing. The Administrative Core will also oversee functioning of the two research cores to foster
their active use by Center investigators (Behavioral) and outreach to attract new investigators to alcohol
research (Pilot Project). Pilot projects (2) funded in years 1, 3 and 5 from funds requested in this proposal, will
be supplemented by additional flexible matching funding provided by the VCU School of Medicine and VCU
Office of the Vice-President for Research and Innovation to enhance their scientific progress. The Pilot Project
core will also help recruit potential additional pilot projects specifically dealing with alcohol/cancer and
alcohol/liver disease interactions. These will utilize additional flexible funding provided by the VCU Massey
Cancer Center and the VCU Stravitz-Sanyal Institute for Liver Disease and Metabolic Health. Ultimately, it will
be the goal of the Administrative Core to oversee function of the Center as a national resource and to continue
expanding the scope and quality of alcohol research at VCU.